BCCMA: Recovery of Aged Muscle After Disuse Atrophy (REMEDY): Targeting energetics and proteostasis in recovery from disuse atrophy

The aging Veteran population has more frequent inpatient hospitalizations than non-Veteran populations. In
older Veterans there is an inability to fully recover muscle mass and function after hospital-acquired weakness.
The consequence of repeated periods of disuse is a hastening of the progression to disability or frailty for older
Veterans. We hypothesize that anticipatory and/or early interventions are critical to maintain muscle mass and
function in older Veterans. To address this hypothesis, our specific aims are to: 1) use pre-clinical models to
understand biological mechanisms of failed regrowth and potential therapeutic approaches, 2) leverage
precision medicine and phenotyping to predict the onset and identify risks and underlying etiology of hospital-
acquired weakness in high risk Veterans with multiple morbidities, and 3) determine clinically viable methods of
characterizing and monitoring disuse muscle atrophy and its impact on physical functioning and resilience.
Studies of old muscle have focused on increasing muscle protein synthesis to accelerate recovery after disuse.
However, our studies have found that protein synthesis is not impaired in old muscle and that other protein
quality control (i.e., proteostatic) mechanisms fail in old muscle. Based on our findings and those of others, we
know that there is impaired mitochondrial bioenergetic capacity in aged skeletal muscle, which gets worse
during disuse atrophy. In Project 1 of REMEDY, we hypothesize that the lack of functional recovery following
disuse-induced atrophy in older animals is related, in part, to a reduction in mitochondrial bioenergetics which
contributes to an inability to maintain proteomic homeostasis (i.e., proteostasis) in skeletal muscle. To test this
hypothesis, we have two Specific Aims: 1) Determine how aerobic and skeletal muscle oxidative capacity
impacts proteostatic mechanisms and recovery from disuse, and 2) Determine if improving aerobic and
skeletal muscle oxidative capacity in older rats leads to better recovery of muscle mass and function following
disuse. To address these specific aims, we will use the high-capacity/low-capacity runner (HCR/LCR) rat model
and the high response/low response to training (HRT/LRT) rat model. These models allow us to independently
test the impact of differences and changes in aerobic mitochondrial aerobic capacity on maintaining muscle
proteostasis and improving recovery from disuse atrophy. For our experiments we will use the well-established
tail suspension model to examine the effects of hindlimb unloading (HU) and reloading (RE) after HU. We will
perform a comprehensive examination of bioenergetics, proteostatic, morphometric, and functional outcomes
of multiple hindlimb muscles at baseline, after HU and during RE. Innovation in the project stems from the use
of HCR/LCR and HRT/LRT rat models to test differences and changes in mitochondrial bioenergetic function.
In addition, we use innovative tracer-based proteomic analyses that we have developed with further
mitochondrial characterization using methods developed by our colleagues in Projects 2 and 3. We expect that
the greater aerobic and mitochondrial capacity of HCR compared to LCR will be associated with better
proteostatic maintenance as evident by fewer protein aggregates during the recovery period, less accumulation
in aggregates of proteins tagged for autophagic or proteasomal breakdown, less ER stress, and less
inflammation. We also expect that the greater increases in aerobic capacity of HRT compared to LRT following
exercise training will result in greater improvements in the same proteostatic mechanisms. Accomplishing this
study will determine if mitochondrial bioenergetic capacity is a potential target to improve recovery after disuse
atrophy in aging Veterans. In addition, our project contributes to the larger REMEDY project by providing a
critical translational intermediate to test potential treatments for clinical implementation.

Public health relevance
PROJECT NARRATIVE Hospitalization and the associated muscle loss with bedrest accelerates progression to disability in older Veterans. The Recovery of Aged Muscle After Disuse Atrophy (REMEDY) collaborative merit seeks to complete the necessary studies to implement a clinical trial targeting the devastating impact of hospital acquired weakness in older Veterans. The current proposal uses the rat hindlimb unloading model to determine how the ability to produce energy in mitochondria impacts recovery of muscle mass and function after a period of disuse. Specifically, we seek to understand if the ability to produce energy can impact the quality control mechanisms of proteins in muscle. It is expected that completion of this study will provide therapeutic targets for the REMEDY project for future clinical trials.